COLLECTION OF MUTANT TYPES OF DROSOPHILA MELANOGASTER

To provide funding for NSF-supported Living Stock collection entitled “Collectioin of Mutant Types of Drosophilia melanogaster” located at Bloomington , Indiana